TENDAI4PrEP: Adaptation of a problem-solving intervention to address individual and provider level barriers to PrEP uptake and adherence among pregnant persons in Zimbabwe

Overview: This proposal directly addresses a critical public health challenge impacting pregnant and postpartum
persons in Zimbabwe: the prevention of HIV acquisition and transmission.
Background/Significance: The risk of HIV acquisition increases three- to four-fold in late pregnancy and early
postpartum. Oral pre-exposure prophylaxis (PrEP) is safe during pregnancy, effective in preventing HIV, and
available in Zimbabwean antenatal care (ANC) clinics. However, PrEP use remains low among cisgender women
of reproductive age. Individual-, interpersonal/community-, and provider-level barriers (e.g., psychological
distress, stigma, low partner support, limited PrEP knowledge in providers) compromise use.
Preliminary studies: In this R34 application, we propose to develop a multi-level PrEP adherence and
persistence intervention as an adaptation and extension of our TENDAI (‘grateful’ in Shona) program, a problem-
solving approach to reduce depression and increase HIV treatment adherence among people living with HIV in
Zimbabwe. To develop TENDAI, we culturally adapted evidence-based adherence strategies and combined
them with problem-solving therapy for depression, targeting depressed mood as a pathway to reduced
antiretroviral therapy (ART) adherence. In participants randomized to the intervention, TENDAI was associated
with increased ART adherence and decreased depression. Therefore, our Zimbabwe-, US-, and UK-based team
has the expertise required to extend TENDAI into a multi-level, problem-solving PrEP use intervention
(TENDAI4PrEP) for pregnant persons with psychological distress, their partners, and antenatal care providers.
Approach: TENDAI4PrEP will support PrEP adherence and persistence during pregnancy among individuals
with psychological distress who have agreed to initiate PrEP use. In Aim 1, we will explore the impact of
intersecting, multi-level barriers to PrEP uptake, adherence, and persistence among pregnant persons as well
as barriers to the provision of PrEP among antenatal care providers. In Aim 2, we will use the formative data to
specify the intervention, likely involving a patient component (inclusive of a dyadic session with a partner) and a
provider component, and conduct a small proof-of-concept trial. In Aim 3, we will evaluate the feasibility and
acceptability (primary outcomes) of (a) the patient-level intervention in a pilot RCT and (b) the provider-level
component in a pre-post design. Secondary outcomes of the RCT will be (1) self-reported PrEP adherence and
(2) psychological distress, both at the end of treatment, and (3) PrEP persistence (measured via dried blood
spots) at 3-month follow-up. Secondary outcomes of the provider component will be PrEP knowledge and PrEP
stigma. We will also explore key implementation outcomes among ANC providers and administrators.
Outcomes/next steps: These aims will lay the groundwork for a full-scale, hybrid effectiveness/implementation
trial which could dramatically improve rates of PrEP adherence and persistence during pregnancy and the
postpartum period, ultimately decreasing HIV prevalence in Zimbabwe.

Public health relevance
PROJECT NARRATIVE Zimbabwe’s HIV prevalence rate is among the highest globally, and cisgender women of reproductive age are disproportionately affected. Considering the increased risk of HIV acquisition and transmission during pregnancy, there is an urgent public health need to develop interventions that increase the use of efficacious HIV prevention strategies like PrEP in the antenatal context. A multi-level, problem-solving intervention that addresses barriers to PrEP adherence and persistence during pregnancy and through the postpartum transition among patients, their partners, and antenatal care providers could improve the health of pregnant persons, ultimately decreasing HIV incidence in Zimbabwe.